Graduate Research Training Initiative for Student Enhancement (G-RISE) (T32) at Rutgers University-Newark

ABSTRACT
The mission of the proposed G-RISE Program is to increase the number of PhDs
underrepresented in the diverse fields of Biology, Chemistry, Neuroscience and
Psychology who will proceed to postdoctoral research fellowships/positions, on a
trajectory to enter the biomedical/behavioral research workforce. To accomplish this
goal, our main program objectives are: 1) to foster in each trainee: self-efficacy in their
chosen specialty, self-identification as a research scientist, and the confidence that they
are integral, contributing members of their scientific community; 2) to develop our
trainees’ technical and professional skills required to conduct research in an ethically
responsible and rigorous manner; 3) to develop our trainees’ didactic, research,
mentoring, and career development skills; 4) to promote our trainees’ timely fulfillment
of the institutional requirements for the Ph.D.; 5) to foster and facilitate each trainee’s
appointment to a postdoctoral position in preparation for entering the
biomedical/behavioral research workforce in their specialty. The rationale for the
current G-RISE proposal is to build on the success of our current IMSD Program (24
PhDs in the last 3 grant cycles and 5 more expected this year) and take the opportunity
to develop programmatic innovations within the G-RISE format. The following key
activities comprise part of the design of the proposed G-RISE Program: 1) Research
Communication Workshop to develop the trainees’ skills in communicating their
scientific research to a multidisciplinary audience, 2) Fellowship Writing Workshop to
foster a knowledge base to develop a fellowship application, 3) Research Career
Preparation seminar series and 4) Responsible Conduct of Research and Research
Reproducibility seminar series. A mentor-training component is included in the proposed
G-RISE program with a healthy balance between established and early career
investigators. The proposed program measurable outcomes are: 1) Earning the PhD
degree; 2) Applying for at least one predoctoral fellowship, 3) Successfully vying for a
postdoctoral research fellowship/position by the completion of the doctorate. Taken
together, the proposed G-RISE Program will continue the development of a successful
training program aimed at fostering the entrance of the trainees into fields of
behavioral/biomedical research in which they have been traditionally underrepresented.

Public health relevance
NARRATIVE The proposed G-RISE Program aims to increase the number of pre-doctoral trainees traditionally underrepresented in the diverse fields of Biology, Chemistry, Neuroscience and Psychology. The program will foster promising careers of trainees on a trajectory to enter the behavioral/biomedical research workforce, by providing them with the training resources and mentoring support to assist them in earning a PhD, competing for fellowships and proceeding to a postdoctoral research position.